Role of CB2R Modulation in HIV-Induced Cathepsin B Neurotoxicity

Project Summary Approximately, 50% of HIV-positive people develop HIV-associated neurocognitive disorders (HAND), despite being under combined antiretroviral therapy (cART). HAND is an inflammatory neurodegenerative disease characterized by increased macrophage infiltration and persistent HIV replication in the brain of affected individuals. There are no effective therapies available against HAND. Our laboratory has found increased expression of cathepsin B, a pro-inflammatory lysosomal enzyme, in postmortem brain tissues of individuals with HAND. In addition, after HIV-1 infection of monocyte-derived macrophages (MDM), secreted cathepsin B changes interactions with other proteins such as serum amyloid P component (SAPC) and promotes neurotoxicity. Thus, targeting cathepsin B represents a potential strategy against HAND. In search for new therapies, it was demonstrated that activation of cannabinoid receptor type 2 (CB2R) inhibits HIV-1 replication in macrophages, reduces blood-brain barrier (BBB) permeability, decreases neurotoxicity to HIV-1 viral proteins, and diminishes pro-inflammatory cytokines release. Nonetheless, studies have shown increased expression of CB2R in in vitro HIV-infected macrophages, and in post-mortem brain tissues of HAND patients. Therefore, this receptor represents a promising target for treatment against HAND. However, the role of CB2R activation in cathepsin B secretion and neurotoxicity has not been studied previously. The overall objective of this proposal is to understand the mechanisms of CB2R activation in cathepsin B secretion and neurotoxicity from HIV-infected macrophages. Our central hypothesis is that CB2R activation will prevent cathepsin B secretion and neurotoxicity from HIV-infected macrophages by attenuating intracellular inflammation pathways in MDM and preventing cathepsin B interactions with SAPC. Our hypothesis was formulated based on results that show a significant decrease in cathepsin B secretion and neurotoxicity from HIV-infected MDM treated with a CB2R agonist. We will test our central hypothesis and, thereby, accomplish the objective of this proposal by pursuing the following specific aims: 1) Determine the effect of CB2R activation in cathepsin B secretion and neurotoxicity from HIV- infected macrophages. 2) Explore the intracellular pathways and characterize cathepsin B interactome in supernatants from HIV-infected macrophages after CB2R activation. 3) Understand the mechanisms of chronic inflammation in HAND. The rationale for this proposed research is that understanding the role of CB2R activation in cathepsin B secretion and interactions will permit the development of strategies against HIV-induced cathepsin B neurotoxicity. This contribution is significant because it will provide new knowledge about the mechanisms of CB2R modulation in cathepsin B-induced neurotoxicity from HIV-infected macrophages, and will contribute to the development of new strategies against HAND.

Public health relevance
Project Narrative Cathepsin B is a lysosomal protease that plays a significant role in the neurotoxicity caused by HIV-infected macrophages, which are the main reservoirs of HIV in the brain. Cannabinoid receptor type 2 (CB2R) activation by agonists decrease cathepsin B secretion, neurotoxicity, HIV-1 replication, and inflammation in macrophages. Therefore, understanding the mechanisms of CB2R activation in macrophages and cathepsin B neurotoxicity will permit the development of alternative strategies against HIV-associated neurocognitive disorders (HAND).